Generation of a Gene-Targeted Human iPS Cell Library for Macular Degeneration

DESCRIPTION: The dry form of age-related macular degeneration (AMD) is the leading cause of visual loss in the adult population, but the molecular mechanisms underlying the pathology of this disease remain unclear. There are no disease-modifying therapies for AMD, and yet a better understanding of the disease process will undoubtedly lead to new therapeutic options for this highly prevalent and devastating condition. The current grant application aims to create a library of gene-targeted human pluripotent stem cells (hiPSC) to better elucidate the pathophysiologic mechanisms of AMD. The initial library to be produced in this work will take advantage of known gene linkages for AMD from genome-wide association studies (GWAS). The clonal cell lines produced for this library will be isogenic differing only in specific single-nucleotide polymorphisms (SNPs) previously identified in the GWAS database. Differentiation of the cells into retinal pigmented epithelial (RPE) will make possible unprecedented studies into the molecular pathogenesis of the inflammatory response and drusen production characteristic of AMD. To efficiently produce libraries of gene- targeted hiPSCs will require the development of advanced techniques for identifying and sorting clonal colonies of hiPSCs which have undergone homologous recombination with the desired nucleotide sequence. To this end, a multidisciplinary team of investigators has been assembled to develop the instrumentation that will enable the rapid identification and efficient separation and collection of gene-targeted cells needed to produce hiPSC libraries. The system will integrate state-of-the-art microtechnologies for cell manipulation and the performance of parallel polymerase chain reactions (PCR). Design, development, integration and validation of the platform will be accomplished in three aims. First, microfabricated cell arrays will be adapted for identification of individual hiPSC colonies using automated algorithms followed by sampling and separation of the microscopic colonies. Second, a microwell plate will be utilized for parallel analyses of gene- targeted hiPSC samples by PCR. The microfabricated sampling array and microwell PCR device will then be integrated to sample, identify, and collect only those colonies composed of properly gene-targeted cells. To benchmark system performance, the platform will be utilized in the production of gene-targeted hiPSC cell lines in parallel with conventional technology, and the two approaches will be compared. Once validated, the platform will be employed to create a library of individual homozygous cell lines containing specific SNPs in the complement system for which expression of the protein products in the eye have been linked to increased or decreased risk of AMD. Using this system the cells will be isogenic at all other loci. These cell lines will then be differentiated into RPE cells for future study of AMD pathophysiology. This technology will make possible the efficient creation of large numbers of specific gene-targeted pluripotent cell lines that will have widespread application in eye research including understanding basic cell biology as well as pharmaceutical screens.

Public health relevance
PUBLIC HEALTH RELEVANCE: This research develops a new technology to efficiently cloning gene-targeted human induced pluripotent stem cells for creating differentiated cell lines that will enable the study of the molecular causes of age-related macular degeneration and other eye disease. This technology is expected to enable production of improved models of human eye disease for understanding the disease process, for pharmacologic screening, and for regenerative medicine applications.